CTSA Postdoctoral T32 at the University of Alabama at Birmingham

Dissemination and implementation (D&I) science is the study of how to effectively translate research findings into practice and policy. By integrating dissemination and implementation science into the clinical and translational science spectrum, researchers and practitioners can better understand the factors that influence the uptake of evidence-based practices and develop strategies to overcome barriers to implementation. However, in the Deep South, there is a critical shortage of professionals broadly. This limits the ability of researchers and practitioners to develop and implement effective interventions to address health challenges and improve health. Hence the objective of this proposed program is to launch the first T32 postdoctoral training program dedicated to the integration of dissemination and implementation science within and across the translational science spectrum. We seek applications from MDs, PhDs, and doctoral candidates, from a wide range of clinical and scientific disciplines and broad regional representation. The proposed program will take full advantage of the stellar resources of the Clinical and Translational Science Center at the University of Alabama at Birmingham and related Deep South Partner Network. The program’s aims are to: [1] Identify, recruit, and train an interdisciplinary cadre of postdoctoral scientists with the knowledge, skills, and experience to become independent investigators who will continue to expand the field of dissemination and implementation; [2] Establish a rigorous, innovative training program in dissemination and implementation science to facilitate nuanced integration of D&I domains within and across the translational science spectrum; [3] Enhance the integration of D&I and clinical and translational science by embracing the health challenges affecting communities served by the Center as a critical, key focus area of scientific advancement. This proposal has 4 distinguishing characteristics: (1) Integration with an NCATS-supported Clinical and Translational Science Hub at UAB and Partner Network comprised of 11 institutions across the Deep South of the US; (2) D&I mentors and resources representing an extraordinary breadth of disciplines across the translational spectrum; (3) A focus on D&I research centered in addressing health needs in the Deep South, and (4) a training design anchored in broad representation. Didactic components leverage coursework developed by UAB and Partner Network investigators and additional UAB programs that have trained generations of scientists in clinical investigation, translational science, and public health research methods. The training duration will be 2 years. We will have 5 slots per year. Successful candidates must show evidence of a strong commitment to D&I science and a commitment to health research. Trainee progress will be monitored and evaluated by the Program Directors, mentors, and advisory committees.

Public health relevance
Dissemination and implementation (D&I) science is the study of how to effectively and efficiently spread evidence-based practices and interventions to the people who can benefit from them. It is important to integrate this type of science into the clinical and translational science spectrum because it helps ensure that new treatments and therapies are not just developed, but also effectively implemented and used in real-world settings. This can ultimately lead to improved health for individuals and communities. This postdoctoral training program will train new scientists in D&I science so we can take better care of people and improve health and reduce health challenges through research.